A novel proteomics approach to identify alcohol-induced changes in synapse-specific presynaptic protein interactions.

Project Summary
Alcohol misuse and addiction is a growing and increasingly destructive socioeconomic national and global crisis.
There is a critical need for novel therapeutic interventions that, rather than managing symptoms, reverse
alcohol-induced neurophysiological changes. One effect that alcohol, and myriad other addicitive drugs, produce
in the brain, is the disruption of long-term synaptic depression (LTD), particularly the presynaptic form of LTD
that occurs at corticostriatal synapses. The striatum is associated with compulsive and habitual behaviors,
including drug addiction. Drug-induced disruption of LTD in dorsolateral striatum (DLS) is associated with
increased habitual behavior whereas LTD restoration restores drug-disrupted goal-directed behavior. We have
found that alcohol disrupts striatal presynaptic mu opioid receptor (MOR)-mediated LTD that, in the DLS, occurs
exclusively at anterior insular cortex inputs (AIC-DLS synapses). MOR-short-term depression at thalamic striatal
inputs are unaffected by alcohol exposure. Identifying the molecular changes that occur presynaptically following
alcohol exposure at AIC-DLS synapses, but not at thalamostriatal synapses, may reveal new targets for
pharmacological interventions in alcohol use disorder and addiction. The specific problem though is that
identifying presynaptic-specific changes in protein-protein interactions using pharmacological and genetic tools
is laborious, inefficient, and relies on a priori knowledge of signaling pathways, likely missing key molecular
players that could be affected. Based on our preliminary data, our central hypothesis is that in vivo alcohol
exposure alters PKA-dependent presynaptic protein organization that is required for MOR-mediated LTD
induction. We will capitalize on the combined physiological and proteomic expertise of the investigators to
develop a novel biochemical methodology that is able to selectively determine the precise ex vivo and in vivo
changes that occur in the protein interactome precisely within AIC synaptic terminals (but do not occur within
thalamostriatal terminals) in DLS during the induction of MOR-mediated LTD and following in vivo exposure to
alcohol. The comparison between these alcohol-sensitive AIC-DLS synapses and the alcohol-insensitive
thalamic inputs will allow us to determine what makes some synapses susceptible to alcohol’s deleterious effects
and others resistant. This methodology employs mouse brain slice electrophysiology, in vivo alcohol exposure,
and viral vector-driven expression of proteins that allow for proximity labeling within presynaptic terminals with
subsequent proteomic analyses. Using this new tool we will open the “black box” of presynaptic proteome
changes that we predict will uncover previously unidentified synaptic plasticity protein-protein interactions that
are disrupted by alcohol and other addictive drugs. Furthermore, we aim to identify novel protein interactions
that may prove to be therapeutic targets for treating alcohol use disorder and addiction.

Public health relevance
Project Narrative A common effect of alcohol and many other drugs of abuse is the disruption of presynaptic long-term synaptic depression in striatal neurocircuits and restoring this lost plasticity may be therapeutic for treating alcohol and substance use disorder and/or pathological sequelae associated with long-term drug abuse. Here we develop an innovative technique to decipher components of the presynaptic interactome that are engaged during the induction of striatal synaptic plasticity at distinct striatal synapses (corticostriatal versus thalamostriatal) that display different forms of plasticity and have differential responses to in vivo alcohol exposure as well as determine how alcohol affects those presynaptic interactomes. In using this novel approach, we hope to identify previously unknown signaling proteins that may be promising therapeutic targets for pharmacological intervention in alcohol use disorder and addiction.